DRP Program

PROJECT SUMMARY
DEVELOPMENTAL RESEARCH PROJECT PROGRAM
The long-term impact of the Arkansas INBRE depends on our ability to enhance the research and
educational environment for faculty and students across Arkansas to develop the next generation of
independent investigators. The Developmental Research Project (DRP) Program will build on previous
successes of the Arkansas INBRE and play a key role in expanding biomedical research capacity in Arkansas.
Through support of biomedical research led by primarily undergraduate institution (PUI) faculty, the DRP
Program will increase opportunities for undergraduate students to participate in biomedical research with the
aim of producing the next generation of biomedical researchers. In order to achieve its goals, the DRP
Program will: 1) provide funding mechanisms for PUI faculty to enable development of biomedical research
programs, 2) in partnership with partner and affiliate PUIs, support recruitment of faculty with expertise to
expand biomedical research capacity within the Arkansas INBRE network, and 3) facilitate and support career
development of PUI faculty who engage in biomedical research. The efforts of the DRP Program will enhance
the biomedical research capacity of the PUIs in the Arkansas INBRE network, provide research opportunities
for undergraduate students at their home institutions, and strengthen the science departments of each
participating PUI.